Association of Discrimination Reported During Pregnancy with Cardiovascular Disease Risk in Mothers

PROJECT SUMMARY/ABSTRACT
Cardiovascular disease (CVD) is the leading cause of death for women in the US. Pregnancy is a key sensitive
period for CVD risk during which rapid maternal cardiovascular changes occur. According to the American Heart
Association, cardiac-related adverse pregnancy outcomes (e.g., hypertensive disorders of pregnancy)
significantly predict future maternal CVD risk. Psychosocial stressors, including discrimination during pregnancy,
may have lasting implications for maternal CVD risk, as greater experiences of psychosocial stress prior to and
during pregnancy are associated with adverse pregnancy outcomes. However, little research has examined the
associations of experiences of discrimination during pregnancy with later maternal CVD risk. The proposed
research examines associations of discrimination during pregnancy with maternal CVD risk at 3-4 years
postpartum, and evaluates whether childhood experiences increase vulnerability to the effects of this association.
This study uses a prospective longitudinal design including a population of at least 200 socioeconomically and
racially/ethnically diverse mothers enrolled in an ongoing longitudinal study (R01MH109662, R01HL155744).
Discrimination, ACEs, and PCEs were assessed during pregnancy, and maternal CVD risk is assessed in the
lab at 3-4 years postpartum. This project has three aims: Aim 1: To test the hypothesis that greater discrimination
during pregnancy is associated with greater overall maternal CVD risk (Framingham-based CVD risk prediction
model) at 3-4 years postpartum. Aim 2: To test the hypothesis that greater discrimination during pregnancy is
associated with increases in individual maternal CVD risk factors (BMI, waist circumference, body fat percentage,
BP, and arterial stiffness) at 3-4 years postpartum. Aim 3 (Exploratory): To test the hypothesis that both higher
adverse and fewer positive childhood experiences in mothers will increase vulnerability to the effect of
discrimination during pregnancy on later maternal CVD risk at 3-4 years postpartum. During the fellowship
period, the applicant will gain essential training at the University of Denver that supports her goal of becoming
an independent NIH-funded researcher. The applicant’s goals include 1) increasing understanding of the
perinatal period as a sensitive period for maternal health; 2) increasing conceptual/methodological knowledge of
perinatal and maternal cardiovascular health; 3) developing expertise in the influences of stressors and resilience
factors on biological and behavioral pathways to CVD risk; 4) developing advanced skills in statistical and
longitudinal analysis; and 5) developing skills in grant-writing. The completion of these training objectives, along
with the strong mentorship from project sponsor (Jenalee Doom, PhD), co-sponsor (Elysia Davis, PhD), and co-
mentors (Josephine Chou, MD, Dana Dabelea, MD, PhD, Deborah Glueck, PhD, and Benjamin Hankin, PhD),
will support this applicant’s goal of becoming an independent researcher.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease (CVD) is the leading cause of death among women, and pregnancy is a sensitive period for the onset of future maternal CVD and a potential window of opportunity to reduce disparities in maternal CVD. This longitudinal study investigates the association of discrimination during pregnancy on maternal cardiovascular disease (CVD) risk and evaluates whether childhood experiences increase vulnerability to the effects of this association. By assessing psychosocial stressors, including discrimination, adverse and positive childhood experiences, alongside CVD risk factors in a diverse cohort of over 200 mothers, this project could elucidate early predictors of maternal CVD and inform targeted interventions for preventing future cardiovascular conditions.